Administrative Core

Administrative Core – Summary
The OK-INBRE Administrative Core provides career development opportunities for faculty, students, and
trainees and provides the logistical support for the overall OK-INBRE network. The Administrative Core also
includes the evaluation component of the network. Oversight, assessment, and evaluation of all OK-INBRE
program activities are provided by the External Advisory Committee (EAC), the Steering Committee (SC)
comprised of a representative from each OK-INBRE network institution, CoBRE PIs, the Oklahoma IDeA-CTR
PI, and the OUHSC and OMRF Vice Presidents for Research. The primary roles of the EAC will be to oversee
the scientific progress of the overall OK-INBRE program, encourage and assist faculty development and
enhancement, identify resources and possible research collaborators as needed, to evaluate progress of the
individual RPI projects. The primary role of the SC will be to oversee the development of the OK-INBRE
network, including oversight of the scientific progress of the network of investigators and rules governing the
composition of the EAC. Oversight and evaluation of the OK-INBRE program will also be provided by the
internal evaluator, Dr. Ann Chou, the American Association for the Advancement of Science, and the OK-
INBRE Deans’ Council. The PI, Dr. Darrin Akins, and the Program Coordinator, Dr. Mel Vaughan, will work as
a team with all oversight committees to continually assess OK-INBRE program outcomes. The Administrative
Core also will provide research and career development activities for faculty at the PUIs, CCs, and our TCCU
partner institution. This Core will also provide coordination for the OK-INBRE Summer Undergraduate
Research Program, which aims to increase the number and quality of graduate program and health care
professional program applications submitted by students in Oklahoma. Career development activities also will
be coordinated by the Administrative Core, including sponsorship of (i) travel awards to faculty, students and
trainees at all levels to attend scientific meetings for increased networking, (ii) lectures, workshops, and
retreats and (iii) enrichment courses and career guidance symposia. The Administrative Core also will provide
reassignment time awards to PUI and CC faculty for development of new courses that incorporate more
experiential activities for students. The Administrative Core Director will be the primary contact for the
nationwide network of INBRE programs and the NIGMS.